The Center for Innovation and Translation of Point of Care Technologies for Expanded Cancer Care Access (CITEC)

Abstract:
Cancers arising in epithelial tissue account for 80‐90% of all cases. Many epithelial cancers could be prevented or cured
by detecting and treating pre‐cancerous lesions and early stage disease. A number of POC technologies have shown
promise to improve cancer screening and early detection of epithelial precancer and cancer, including both in vitro and in
vivo imaging tools, and molecular sensors. However, development and translation of POC technologies are slowed by
multiple technical and clinical barriers. The Center for Innovation and Translation of Point‐of‐Care Technologies for
Equitable Cancer Care (CITEC) is structured to offer “one‐stop shopping” to address these barriers. CITEC will support and
accelerate the development, delivery and equitable use of affordable, effective and accessible POC technologies to screen
and/or detect epithelial precancer and early cancer. The Administrative Core will provide overall project oversight and
management to ensure that all CITEC cores function at a high level, that cores collaborate effectively to achieve the overall
goals of CITEC, and that CITEC is responsive to and synergistic with the goals of the overall POCTRN network.
The first aim of the Administrative Core is to establish and manage the administrative structure, governance policies,
decision making, budget management, and conflict resolution processes and communications plans for the Center. The
CITEC program will be overseen by a CITEC Steering Committee, consisting of the PD/PIs and co‐leads of Cores with equal
voting rights. The CITEC Steering Committee will review progress of cores and individual projects, develop collaborative
protocols, identify technological impediments to progress, select strategies to surmount them and identify opportunities
for sharing techniques and tools developed within individual projects. The Administrative Core will also have primary
responsibility for interactions with NIH and will work with NIH to advance efforts to reach the goals of POCTRN.
The second aim of the Administrative Core is to work to continuously evaluate and improve CITEC, partnering with the
leadership of the Cores to gather and analyze data to identify challenges in optimizing the impact of CITEC activities. To
achieve this aim, the Administrative Core will assist CITEC Cores to build multidisciplinary partnerships; to ensure inclusion
of a diverse community of partners and stakeholders; and to evaluate performance and guide performance improvement.
The AC will develop review mechanisms to ensure that project resources are used effectively to accelerate the
development, translation and equitable implementation of POC technologies to improve cancer screening and early
detection.
The AC will establish an External Advisory Committee; CITEC performance data will be shared with the External Advisory
Committee and, with their feedback, will ensure that CITEC engages in effective continuous quality improvement.
In short, the Administrative Core will support robust, productive and efficient interactions between CITEC members,
funded investigators, the POCTRN network and relevant stakeholders.

Public health relevance
According to Instructions for the Submission of Mulit-Component Applications in PAR-22-203, for Administrative, Technology, Clinical and Dissemination Cores: “Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.”